LEAD AND SKELETAL HEALTH IN BOSTON AREA WOMEN

This study is designed to explore the hypothesis that lead intoxication or chronic mild/moderate increases in lead levels alters bone mineral content in humans.